Calcium/ Calmodulin Activated Kinases in Smooth Muscle

Project Summary: This ongoing research project is aimed at defining functions of multi-functional
serine/threonine Ca2+/Calmodulin-dependent protein kinase II (CaMKII) isozymes in injury- and disease-
induced vascular remodeling. CaMKII is structurally complex and is expressed as a large hetero-multimeric
holoenzyme with 12-14 individual kinase subunits. CAMK2 genes undergo extensive alternative splicing to
produce variants that can affect holoenzyme subcellular localization and protein interactions. The central
hypothesis is that cell-specific expression and activation of CaMKII isoforms and splice variants are functional
determinants of integrated vascular remodeling in response to injury and disease.
The first specific aim extends our expertise in CaMKII structure and function in vascular smooth muscle to the
vascular endothelium, in the context of an in vivo mouse model of intraluminal arterial injury that simulates
aspects of in-stent restenosis. The functions of vascular endothelial cell CaMKII isoforms in re-
endothelialization following intraluminal injury are tested by conditional knockout of specific Camk2 genes in
genetically engineered mice. Regulation of the CaMKII isoform by STAT3 and the role of CaMKII in
mediating STAT3-dependent functions are tested in this inflammatory environment. The second specific aim
capitalizes on knowledge of CaMKII variant expression in vascular smooth muscle and tests the functional
significance of an alternatively spliced c-terminal amino acid sequence in CaMKIIthat mediates formation of a
CaMKII/Fyn complex, and subsequent regulation of cellular processes involved in vascular smooth muscle
cell motility and proliferation A novel CaMKII antisense exon-skipping oligonucleotide (ESO) approach,
designed to precisely interfere with expression of this sequence has been validated in vitro. ESOs will be
administered to mice prior to intraluminal arterial injury with the goal of limiting vascular smooth muscle
migration to the intima and subsequent neointimal hyperplasia, without affecting vasculoprotective endothelial
regeneration. The final aim investigates the function of CaMKII isoforms in promoting programmed cell death
by necroptosis in vascular smooth muscle and the role of this mechanism is promoting progression of
abdominal aortic aneurysm. This aim is carried out in collaboration with labs at Augusta University and the
University of Wisconsin and is investigated using mouse models of aortic aneurysm and conditional knockout
of specific Camk2 genes in vascular smooth muscle.
Relevance: Accomplishing these aims will provide detailed information on the functional importance of specific
CaMKII isoform variants in vascular injury, in stent-restenosis and aneurysmal disease. Application of
antisense ESOs targeting CaMKII may provide novel therapeutic approaches to mitigate progression of
vascular disease.

Public health relevance
Vascular remodeling in response to injury or disease is a multicellular response with vascular endothelial cells as major sensors and drivers of underlying medial wall vascular smooth muscle function. Intracellular calcium signals induced by contractile stimuli, chemokines, mechanical stimuli and growth factors can contribute to endothelial and vascular smooth muscle functions, including motility, cellular proliferation, extracellular matrix remodeling, and pro-inflammatory function. The multifunctional serine/threonine Ca2+/Calmodulin-dependent protein kinase II (CaMKII) is a key transducer of calcium signaling. CaMKII isoform expression and the relative isoform composition of CaMKII holoenzymes, is a determinant of vascular remodeling in response to injury. The proposed studies will test the regulation and function of CaMKII isoforms in endothelial regeneration and neointimal hyperplasia in response to intra-luminal vascular injury, and for the first time functions of CaMKII isoforms in promoting progression of mouse abdominal aortic aneurysm, with translational relevance to a significant clinical problem.